Administrative Core

PROJECT SUMMARY
The PROTECT (Puerto Rico Testsite for Exploring Contamination Threats) Superfund Research Center (SRC)
includes four research projects, two research support cores and three required enrichment cores, one of which
is the Administrative Core. The primary objective of the Administrative Core is to provide a formal structure for
oversight, planning, coordination, and promotion of cross-disciplinary, multi-university interaction by projects
and cores. The secondary, equally vital objective is the translation of research to stakeholders.
The specific aims of the Administrative Core are to (1) provide center direction and planning, (2) provide fiscal
management and administrative services, (3) maintain active communication with NIEHS/SRP; (4) promote
center activities and research results to all relevant stakeholders in scientific communities, government, and
industry, and (5) develop investigator-initiated research translation activities for each project, including
technology transfer and training on research translation.
To accomplish these aims requires a sophisticated administrative structure, particularly for a geographically
distributed, multi-university team. Substantial planning, organization, and effective communications tools
promote active collaboration and coordination. To this end, the Administrative Core has developed a
framework that links projects, cores, institutions and participants. This includes highly-qualified and
experienced Center Directors who manage and guide PROTECT research, training and stakeholder
engagement activities; an Executive Committee to manage, facilitate and monitor the technical quality of
projects and cores; a Research Translation Coordinator to oversee research translation at the project and
center levels, and a dedicated Administrative Staff who support PROTECT research and administrative
activities using appropriate information technology, financial and reporting software and communications tools.
To advise and guide the effort, an External Advisory Committee formed of four subcommittees focuses on
important issues; the Scientific Advisory Committee assesses research merit, cross-disciplinary integration,
translation and relevance; the Institutional Partnership Advisory Committee provides necessary institutional-
level guidance and promotes long-range strategic goals; and Training, and Community Engagement Advisory
Committees support their respective cores. Frequent, routine management and coordination/integration
meetings are planned for optimal participation by PROTECT personnel and advisors. This effective strategy
has been used since PROTECT was established in 2010, resulting in collaboration and integration across
projects, cores and institutions, successful communication with advisory committees and external
stakeholders, and timely, accurate financial tracking and progress reporting to NIEHS/SRP.

Public health relevance
PROJECT NARRATIVE The Administrative Core provides a formal structure for oversight, planning, coordination, and promotion of cross-disciplinary interaction among all of the projects, cores, and participating institutions, as well as translation of research to stakeholders. The leadership and guidance provided by the Administrative Core is necessary to fulfill the ultimate goal of PROTECT: to understand the impact of environmental contamination on adverse pregnancy outcomes in Puerto Rico and beyond.